Hypoxia inducible factors in shaping neuroinflammation and Alzheimer's pathogenesis

PROJECT SUMMARY/ABSTRACT
Alzheimer’s disease (AD) is the most common form of dementia, and as the population ages, it presents an
enormous public health challenge with increasing urgency. Neuroinflammation is recognized as a major
contributor to late-onset AD. However, the molecular modifiers for the neuroinflammatory response and key AD
risk factors that hold such capacity remain unclear. Oxygen deprivation triggers a rapid adaptive response called
hypoxia that stimulates anaerobic metabolism and angiogenesis to protect the host. In the past decade, a close
connection between hypoxia, immunity, and metabolism has been firmly established in normal tissues and
various disease conditions. The brain is the body’s most energy-demanding organ owing to its high metabolic
rate, and oxygen is the most vital element in the human body, especially the brain. Despite this, a molecular
understanding of how hypoxia modifies AD pathogenesis, specifically neuroinflammation, is currently lacking.
Activation of neuroinflammatory responses is intimately linked to AD pathogenesis. In sporadic AD, immune-
related genes are significantly upregulated, and multiple AD risk genes modify the function of microglia, which
are brain-resident immune cells. We have identified that type I IFN (IFN) cytokine, a key component of antiviral
innate immunity, is produced from plaque-associated microglia and promotes various aspects of neural
pathology in diseased brains. Additionally, we detected an elevated IFN response in human tau pathology and
found co-induction of IFN and hypoxic responses in tau-expressing neurons. Moreover, we recently discovered
a synergistic interplay between IFN and hypoxia in glial inflammation. Obstructive sleep apnea, cerebral
ischemia, stroke, and heart failure invariably promote brain hypoxia and increase the risk of AD. AD brains also
display reduced cerebral blood ﬂow, and cerebral hypoperfusion increases deposition of β-amyloid and
phosphorylated tau proteins. Despite the strong implication of hypoxia, the functional involvement of hypoxia-
inducible factors (HIFs), the master regulators of the hypoxia response, in AD is largely unknown. Based on our
preliminary findings, we hypothesized that HIFs play a critical role(s) in AD-related tauopathy by affecting
microglial function and promoting neuro-inflammation. We propose three specific aims - Aim 1: Map HIF-driven
activity in brains with progressive tauopathy; Aim 2: Elucidate the essential roles of microglial HIF1αs in
tauopathy; and Aim 3: Examine the impact of microglial overstabilization of HIFαs on tauopathy. Here we will
gain fundamental knowledge of intrinsic hypoxic response as well as the essential roles of microglial HIF1α vs
HIF2α in AD-related tauopathy.

Public health relevance
PROJECT NARRATIVE Most patients with conditions limiting brain oxygen levels have a high risk of developing Alzheimer’s disease (AD). We have discovered a pathogenic inflammation pathway that is activated in the AD brain and further enhanced by a lack of oxygen. Here, we plan to study in detail how factors activated by low oxygen increase brain inflammation and contribute to AD, with the hope of finding specific molecules as targets for AD treatment.